Untangling the diversity in the genetic architecture of late-onset Alzheimer's disease using single cell multi-omics

ABSTRACT
Late Onset Alzheimer's Disease (LOAD) genome wide association studies (GWAS) discovered numerous loci.
But there remains an unmet need to translate the GWAS findings to disease mechanisms through the
identification of the specific genes involved, the causal variants, and the molecular mechanisms by which they
exert their pathogenic effects. Most LOAD-associated SNPs are in noncoding regions pointing to gene
regulation as an important disease mechanism. Another challenge in LOAD genetics is diversity, as most
studies were conducted in subjects from European ancestry, while other populations are largely understudied.
Our central hypothesis is that LOAD-specific epigenomic signatures, as well as noncoding functional genetic
variants result in dysregulation of genes with key roles in LOAD pathogenic biological pathways. While omics
studies using bulk brain tissue from European ancestry donors have produced informative data for a few
genes at LOAD loci, single-cell omics data from brains of patients and controls from diverse populations will
provide new knowledge in unprecedented brain cell-subtype precision across multiple racial and ethnical
groups. We will investigate the relationships between LOAD-specific gene expression, chromatin accessibility
and genetic variability in European and African ancestries by single-nuclei multi-omics approaches following
three specific aims. Aim 1 will generate matched single-nuclei (sn)RNA-seq and ATAC-seq datasets using the
10X Genomics platform (Single Cell Multiome) to characterize cell-subtype specific changes in transcriptomic
and chromatin accessibility landscape, respectively, in LOAD compared to control, that are shared and distinct
across European and African ancestries. Aim 2 will integrate these datasets to identify open/closed chromatin
sites that function as regulatory elements to impact gene expression in LOAD state, which will be then
validated in the relevant cell-subtype using isogenic hiPSC-derived models by CRISPR/Cas9 genome editing.
Aim 3 will identify LOAD specific gene regulatory variants within specific brain cell-subtypes through
integrative single-cell genomics. We will perform expression(e)QTL and chromatin(c)QTL analyses by cell-
subtype focusing specifically on the QTLs that fall within previously published GWAS regions to determine
whether GWAS signals can be explained by the identified regulatory interactions. We will then catalogue the
SNPs that identified as both strong and significant eQTL and cQTL and prioritize those that predicted to
affect transcription factor binding sites. Last, we will validate the top prioritized variants in genome edited
isogenic hiPSC-derived models. Successful accomplishment of these aims is expected to be high impact as it
will advance the understanding of the genetic complexity underpinning LOAD in diverse populations and will
decipher the regulatory elements and the corresponding genes mediating LOAD risk. This knowledge will be
translational by promoting the refinement of Polygenic Risk Scores, and the development of novel therapeutic
targets for LOAD based on manipulation of dysregulated genes.

Public health relevance
PROJECT NARRATIVE Late onset Alzheimer's disease (LOAD) is a critical unmet medical need and the disease process starts decades before plaques or tangle neuropathologies are detectable; thus, identifying early individuals at-risk in diverse populations and administering interventions in the preclinical stage will be beneficial. Although genetics contributes to the risk to develop LOAD, the precise genetic factors in diverse populations, their mechanisms of action and the brain cell-type in which they exert their pathogenic effects remain largely unknown. Our study seeks to uncover the genetic and genomic causes underpinning LOAD in diverse populations in unprecedented brain cell-type precision. The outcomes will advance the discovery of preventive therapies and/or delay onset treatments targeting molecular events that occur early; years before the manifestation of neuropathological changes and clinical symptoms.